Probing SNARE assembly and disassembly in vitro and in live cells

PROJECT ABSTRACT/SUMMARY
Intracellular vesicle fusion is primarily mediated by SNAREs (soluble N-ethylmaleimide sensitive factor
attachment protein receptors), which consist of vesicle membrane protein synaptobrevin II (syb2, VAMP2 or v-
SNARE), and target membrane proteins syntaxin (syx) and SNAP-25 (collectively called t-SNAREs). As the
vesicle approaches the target membrane, the v-SNARE and t-SNAREs assemble in a zipper-like manner to form
a vesicle fusion machine, enabling release of the molecular cargo. After fusion, the assembled SNARE complex
is disassembled by the recycling machinery, composed of NSF and α-SNAP, into individual proteins for the next
round of fusion. Since vesicle fusion is a ubiquitous process and is critical for cell-cell communication, mutations
in SNAREs lead to numerous neuronal and metabolic diseases. Over the past few decades, extensive studies
have revealed great details of individual steps in the SNARE cycle. However, the molecular mechanism that
orders the sequence of each step remains unclear. A pressing need exists to probe this relationship. Here, we
seek to understand the assembly and disassembly of SNAREs in vitro and in live cells. In Aim 1, we will develop
a hydrogen deuterium exchange-mass spectrometry (HDX-MS) approach to analyze SNARE complex formation
and deformation in vitro under physiologically relevant conditions. We have shown that the sequence coverage
collected after MS of the individual SNARE proteins includes their SNARE motifs, supporting that subsequent
HDX-MS will reveal details into their mechanism. We will use this approach to study SNARE binary and ternary
complex to examine assembly, then introduce the recycling proteins to assess complex disassembly. In Aim 2,
our objective is to understand the spatiotemporal regulation of the SNARE cycle during vesicle exocytosis by
developing a genetically encoded intensity-based conformational sensor for SNAREs assembly and disassembly
(icsenSNARE). Using reconstituted assays, we have identified the first design, icsenSNARE000 that showed a
1.5-fold fluorescence increase upon assembly of the SNARE complex and could be reversed by the disassembly
machinery. Finally, we plan to employ icsenSNARE in live cells to reveal how the spatiotemporal regulation of
the SNARE cycle is coupled to vesicle fusion. Together, the proposed study will advance mechanistic
understandings of vesicle exocytosis, develop a new approach for studying SNARE assembly and disassembly,
and generate a new probe for the SNARE proteins. Achievement of this work has the potential to help study
SNARE-related pathologies to improve human health.

Public health relevance
PROJECT NARRATIVE We aim to develop a hydrogen deuterium exchange-mass spectrometry approach to examine the assembly and disassembly of SNARE proteins reconstituted in lipid nanodiscs in vitro and engineer a fluorescent sensor to study how the SNARE cycle is spatiotemporally linked to vesicle exocytosis in live cells. Achievement of these goals will provide a new means to answer questions related to membrane trafficking and SNARE pathology that are prevented from being addressed due to shortcomings in current technology. This work has the potential to help study the neuronal and metabolic diseases that arise from SNARE mutations.